Novel Transcription Factors in Stimulant and Opiate Action

PROJECT SUMMARY/ABSTRACT– PROJECT 1
Project 1's objective is to characterize several novel transcription factors, not previously implicated in
addiction, in mediating the lasting actions of stimulant and opiate drugs of abuse in nucleus accumbens (NAc)
and prefrontal cortex (PFC). Virtually all prior studies of transcription factors in addiction have taken a
candidate approach. This is in marked contrast to an unbiased approach of using “big data” to deduce, in an
open-ended manner, those factors that are most important in mediating specific aspects of the complex
addiction phenotype. We utilize this more powerful approach by taking advantage of large-scale RNA-seq and
related datasets from rodent addiction models and humans with substance use disorders to identify those
factors that appear to play particularly critical roles in drug action. We focus on cell type-specific actions of
three of the most highly ranked transcription factors from our PPG’s datasets: E2F3, ZFP189, and RXR. For
example, ~25% of all genes that display primed or desensitized changes in expression in NAc as a result of
past cocaine self-administration are predicted to be direct targets of E2F3. Based solely on these
bioinformatics predictions, we have generated robust preliminary data to validate the importance of each of
these transcription factors in drug addiction and now propose to better understand their actions. We will
complete characterization of their role in NAc in controlling behavioral responses to cocaine in self-
administration assays as well as map their target genes on a genome-wide basis. Both of these efforts will be
performed in a cell type-specific manner, as we have evidence for some of the factors playing different roles in
different neuronal types in this brain region. This work in animal models will be complemented by studies of
humans with cocaine use disorders, where we already have preliminary evidence for their abnormal regulation.
We will extend these studies to PFC, where we have found that a different E2F3 splice isoform controls
behavioral and genomic responses to cocaine, as well as to opiate models where we know that these factors
also show prominent dysregulation. Together, this work will reveal new transcriptional mechanisms underlying
cocaine and opiate addiction.

Public health relevance
PROJECT NARRATIVE – PROJECT 1 Addiction remains one of the world’s greatest public health problems, yet its pathophysiology remains incompletely understood and available treatments for addictions to various drugs of abuse are inadequately effective for most people. The Project’s focus on transcriptional regulation is a critical part of this Program Project Grant’s efforts to contribute to a better understanding of the neurobiological basis of addiction, which we believe will facilitate the eventual development of definitive treatments and cures for substance use disorders.